Brain MRI to pre-symptomatically predict seizure onset for Sturge-Weber Syndrome

Abstract
Sturge-Weber syndrome (SWS) is a rare neurological disease, and its biggest concern is neurocognitive
impairments by school age (6-10 years). To improve neurocognitive outcomes, Kenndy Krieger Institute (Dr.
Comi, co-PI of this R21) and Boston Children’s Hospital (Dr. Pinto, co-PI of this R21) have been the leading or
key sites in various clinical trials, to test new treatment (NCT02332655 (2014-19); NCT0304980 (2017-19);
NCT04447846 (2019-21)), or to develop neuroimaging biomarkers that can select at-risk patients
(NCT01345305 (2010-2012); NCT01425944 (2010-2020); NCT04717427 (2021-2024)). However, all these trials
focus on the post-symptomatic phase – after seizure symptoms have occurred. Our recent evidence suggested
that pre-symptomatic treatment – treating patients before seizure symptoms occur, ideally before 2 years of
age – may delay or avoid seizure symptoms. This is important, because those without seizure symptoms by 2
years of age (10-25% of SWS patients) often enjoy good neurocognitive outcomes by school age. Motivated by
this, multidisciplinary experts gathered and reached a consensus in 2018, 2019, and 2021, calling for immediate
investigations of pre-symptomatic treatments. In a timely response to this call, KKI and BCH, the two largest
national centers that treat SWS pre-symptomatically, are planning for a trial to comprehensively evaluate the
effect of anti-epilepsy drugs Levetiracetam, in two treatment arms (Levetiracetam with versus without low-dose
aspirin) for pre-symptomatic treatment. The bottleneck issue for this planned trial, though, is the lack of a
biomarker to accurately and pre-symptomatically identify SWS patients who are at risk to develop seizure
symptoms by 2 years of age. Those at-risk patients should be ideal candidates to be included in our planned
trial. This R21 aims to address this bottleneck biomarker problem. We plan to retrospectively build the largest
multi-site presymptomatic database from clinical data in KKI and BCH (Aim 1). We will thoroughly evaluate two
clinical and brain MRI biomarkers to identify at-risk patients pre-symptomatically (Aim 2). The central
hypothesis is that sophisticated features that artificial intelligence (AI) algorithms extract from clinical and brain
MRI could serve as a biomarker to pre-symptomatically identify SWS patients at risk of developing seizure
symptoms by 2 years of age. This is the first AI-powered, large-dataset-driven rigorous study for presymptomatic
clinical and MRI biomarkers for this rare disease. Such a biomarker will be immediately used in our planned
clinical trials to evaluate Levetiracetam with or without low-dose aspirin for pre-symptomatic treatment.

Public health relevance
Project Narrative Current clinical trials for a rare neurologic disease Sturge-Weber syndrome (SWS) are all testing treatment strategies in the post-symptomatic phase (after seizure symptoms have occurred), but emerging evidence and very recent multidisciplinary expert consensus in the field call for immediate actions to investigator pre- symptomatic treatment, so to intervene early for higher effectiveness to improve neurocognitive outcomes in SWS patients. Kenndy Krieger Institute and Boston Children’s Hospital, the nation’s two largest SWS care centers that treat SWS pre-symptomatically (before seizure symptoms occur, and ideally before 2 years), are planning the first clinical trial to comprehensively evaluate an anti-epilepsy drug Levetiracetam, with and without low-dose aspirin, for treating SWS pre-symptomatically. This R21 is to prepare for this first multi-site pre- symptomatic trial, by thoroughly evaluating neuroimaging biomarkers for pre-symptomatically identifying most vulnerable SWS patients (i.e., those at the highest risk to develop seizure symptoms by 2 years) in a large-scale multi-site database.